The Molecular Basis of Staphylococcus aureus SplB manipulation of the host

PROJECT SUMMARY
While bacteria broadly secrete multiple virulence factors during infection to modulate the host cell
machinery for infection, S. aureus is unique in that most strains encode for a distinct protease family of up to six
members, broadly referred to as serine proteases-like A-F (SplA-F). Spl family members do not respond to
standard serine protease inhibitors, highlighting their unique active siteS. For example, the structures of Spl
family members alone reveal such shallow active sites that they have been proposed to be reliant on
conformational changes for target recognition. Furthermore, a novel conformational “switch” that allosterically
couples the N-termini of Spl family members to their active sites has been proposed to underlie their zymogen
activation {Pustelny, 2014 #3042}. Thus, conformational changes and allostery underlie Spl function through
unknown mechanisms. Our lab has developed NMR-based methods to specifically identify the role of
conformational changes and allostery in enzyme function. Based on our preliminary biological studies that have
identified SplB as the most highly expressed Spl family member, we have begun identifying SplB host targets
and applying NMR-based methods to elucidate its target interactions and underlying allosteric mechanism of
activation.
We hypothesize that S. aureus SplB targets multiple host proteins (Aim 1), which induce target-
dependent conformational changes (Aim 2). Activation of the SplB zymogen via N-terminal cleavage leads to
both global structural and dynamic changes that facilitate active site opening and target entry (Aim 3). This
hypothesis will be tested through the following specific aims:
Aim 1) Identify host protein targets of S. aureus SplB. Rational-based approaches together with unbiased
methods will be used to broadly identify SplB host targets and their cleavage sites will be identified by mass
spectrometry (MS). Target sequences will be biochemically validated by inserting them as linkers within a fusion
protein.
Aim 2) Elucidate the conformational changes required for SplB engagement with host targets. High-
resolution NMR structural methods will be used to determine how SplB targets are engaged and whether there
are target-specific conformational changes.
Aim 3) Identify the allosteric mechanism of SplB activation and the role of dynamics in SplB function.
High-resolution NMR structural methods will be used to determine the structural basis of SplB zymogen
activation, i.e., the allosteric “switch,” while NMR relaxation methods will be used to determine the dynamic basis
of activation and the role of dynamics in function.

Public health relevance
NARRATIVE S. aureus is unique among bacteria for having a distinct family of six serine proteases, known as SplA-F, that drive infection of the host. We have discovered that SplB expression is the highest of these family members within the most common S. aureus strain affecting North America. Here, we will broadly identify the SplB host targets and utilize NMR to understand how this enzyme targets host proteins and its molecular mechanism of activation.